Assessing the effectiveness of Screening, Brief Intervention, and Referral to Treatment (SBIRT) to reduce polysubstance impaired driving among emerging adults aged 18-30 in Washington State.

PROJECT SUMMARY
Screening, Brief Intervention, and Referral to Treatment (SBIRT) is an evidence-based comprehensive
approach that can 1) quickly screen individuals for at-risk alcohol and other substance use and mental health
issues, 2) utilize in-the-moment delivery of brief (i.e., 5-10 minute) intervention with motivational interviewing
techniques and 3) when needed, provide referral to treatment. Regarding alcohol-impaired driving, SBIRT has
been shown to be efficacious in reducing self-reports of drinking and alcohol-impaired driving, reports of
alcohol-related vehicle crashes, and increasing referrals to treatment. Given the success of SBIRT for alcohol-
impaired driving it may also be impactful for polysubstance-impaired driving. However, to date there has been
limited evaluations of SBIRT regarding its effects for polysubstance-impaired driving. Despite the potential of
SBIRT to reduce polysubstance-impaired driving, reported barriers include competing priorities for staff to
provide SBIRT, staff turnover, and availability of treatment options. Brief motivational interventions (BMI) have
evidence for reducing alcohol and cannabis use and consequences among young adults with additional
previous support for reducing impaired driving. Web-based personalized feedback intervention (PFI) adapted
from these in-person BMI may also be effective in reducing impaired driving and would address limitations
within the SBIRT framework. Our team is contracted to roll out SBIRT training with 200 facilitators between Jan
2025-Sept 2025, which will include updated material specific to alcohol- and polysubstance-impaired driving.
The proposed project would leverage this newly trained network and provide a web-PFI (SBIRT+PFI) to their
young adult clients who screen at moderate or moderate to high risk or have any reports of impaired driving.
Consented young adults would be randomized to receive the PFI or waitlist control and be assessed at
enrollment and 3 months later. We also will collect data from the SBIRT facilitators to garner information on
sustainability and barriers of implementing SBIRT. Thus, the objectives of this project will be to 1) examine the
changes in polysubstance-impaired driving among young adults among those who receive the expanded
SBIRT+PFI, and 2) using both qualitative and quantitative approaches, document real-word successes and
difficulties in sustaining SBIRT models including: a) barriers to implementing with fidelity and b) percentage of
staff turnover. Findings of the project can help inform decisionmakers and policymakers on the value of SBIRT
and SBIRT+PFI for polysubstance-impaired driving as well as considerations for continued sustainability.

Public health relevance
PROJECT NARRATIVE Polysubstance-impaired driving (i.e., driving under the influence of 2 or more substances) is a dangerous public health concern that has received relatively little attention regarding evaluation of prevention and intervention strategies. Screening, Brief Intervention, and Referral to Treatment (SBIRT) is a comprehensive approach that has shown success for alcohol-impaired driving but has yet to be examined regarding polysubstance-impaired driving and, in its current standard of care, may miss opportunities to provide additional intervention to those at increased risk of impaired driving. The information garnered from the present application’s examination of an extension of SBIRT that provides a web-based personalized feedback intervention(PFI) to young adults who are at increased risk, and exploration of SBIRT’s implementation sustainability of through interviews and surveys from SBIRT facilitators can inform healthcare decisionmakers and policymakers about the effectiveness of SBIRT and SBIRT+PFI, which could reduce injuries, fatalities, and legal ramifications for young adults.